Intense Noise Exposure Impacts Performance of Vestibular Dependent Behaviors

Abstract
Military personnel are exposed to intense noise during their active duty careers from weaponry, explosions and
military vehicles such as tanks, helicopters and other aircraft. Exposure to intense noise causes hearing loss
and may also cause vestibular dysfunction. Although hearing loss and cochlear synaptopathy are well studied,
peripheral vestibular synaptopathy and vestibular dysfunction are less often studied and poorly characterized.
Furthermore, age related balance deficits are a significant public health problem for veterans in the United States.
Agrawal et al. reported that 35% of adults older than 40 had evidence of postural instability and balance
dysfunction increased with age so that by 80 years, 85% of adults reported balance problems. Vestibular
dysfunction can increase the likelihood of falling; in the US falls are responsible for significant decrements in
quality of life, and more than 50% of accidental deaths. Although the causes of postural instability are complex
and multifactorial, several studies demonstrate a linkage between noise induced hearing loss and vestibular
dysfunction in humans. Noise exposure as a risk factor for vestibular loss has obvious and significant veteran
health implications, but there are few, if any studies that (1) provide insights into the physiology that underlies
noise-induced vestibular loss and (2) provide guidance for preventative or rehabilitative strategies for veterans
with balance disorders. The proposed studies will show in a rat model, that noise exposure at levels encountered
by veterans during their military service and during daily life can cause vestibular dysfunction that includes
deficits in vestibular reflexes and vestibular signaling that increase fall risk and reduce head stability and visual
acuity during movement.
We hypothesize that intense noise exposure sufficient to attenuate vestibular nerve responses to linear
acceleration (as assessed by the Vestibular short latency Evoked Potential (VsEP) will also cause significant
functional deficits in three vestibular dependent behaviors, (1) control of balance during locomotion; (2) deficits
in vestibulocollic reflex function that reduce head stability; and (3) deficits in vestibulo-ocular reflex function
sufficient to reduce visual acuity during locomotion.
Specific Aim 1. Assess balance, head, and visual stability in rats exposed to intense noise sufficient to abolish
VsEP responses for at least 28 days. We will use this time window to probe the time course and nature of
deficits in vestibular dependent behaviors caused by noise exposure. Specific Aim 2A. Determine whether or
not the same behaviors are impaired by a single noise exposure that induces temporary loss and recovery of
VsEP responses within 28 days. This Aim will determine if there is a functional vestibular impact from a single
noise exposure after which peripheral synapses and VsEP responses recover. Specific Aim 2B. Determine
the extent to which and the time course over these behaviors are impaired by multiple noise exposures that
initially induce temporary attenuations of VsEP responses. This Aim will determine the cumulative vestibular
impact of repetitive noise exposures (as would typically be experienced by Veterans during their service years)
on potential peripheral and central recovery mechanisms that can be targeted by rehabilitative strategies.

Public health relevance
Project Narrative Noise exposure during their military careers and over their lifetimes could be an unrecognized but significant factor in vestibular disorders prevalent in aging Veterans. A recent study found that ~69 million US adults over the age of 40 have a balance disorder involving the inner ear and many of these patients also suffer from noise induced or occupational hearing loss. The proposed experiments will characterize noise induced vestibular dysfunction in an animal model, a necessary first step for development of preventative and rehabilitative strategies for this population.